National Capital Area (NCA) Minority/Underserved NCORP

Abstract
The National Capital Area (NCA) Minority/Underserved NCORP will be based at Georgetown Lombardi
Comprehensive Cancer Center (LCCC), comprising Medstar Georgetown University Hospital (MGUH) and
MedStar Washington Hospital Center (MWHC) as the primary affiliate, with a catchment area comprising 48.3%
non-Latino Blacks (NLB) and 10.6% Hispanics/Latinos (H/L) that includes Washington, D.C. and adjacent
counties in Maryland and Virginia. MWHC serves predominantly, i.e., > 85% minority and underserved
populations; and treats more than 2,000 predominantly minority cancer patients and 48,000 outpatients,
annually. The cancer burden and disparities are greatest among NLB population in the catchment area as
evident by some of the highest mortality rates in the nation for breast, prostate, and colorectal cancers. Among
the H/L population, cancer is the leading cause of death with H/L patients typically presenting at a later stage
compared to Non-Latino White (NLW) patients. High rates of preventable cancer risk factors such as obesity,
physical inactivity, and smoking, coupled with much lower screening rates for certain cancers, such as colorectal
and cervical cancers in minorities contribute to the cancer disparities seen in the catchment area. The NCA
NCORP proposes to address one of the most significant factors associated with these cancer disparities - limited
access to optimal and cutting edge prevention, cancer control, and cancer care delivery by increasing awareness
and providing access to cancer clinical trials among NLB and H/L in the catchment area. LCCC’s Office of
Minority Health and Health Disparities Research (OMH), represents the community outreach arm that is led by
Dr. Adams-Campbell, that has established viable academic-community partnerships that enable the NCA
NCORP to conduct clinical research in areas of prevention, control, screening, health disparities, and cancer
care delivery among the minority populations of interest. In light of an aging population and the increasing number
of cancer survivors, this NCORP has the expertise and leadership as evident by demonstrable research in these
areas that address cancer control and patient centered cancer care delivery. Furthermore, the ability to address
cancer prevention and control among adolescents and young adults (AYA) is also a key strength of our team.
The NCA NCORP will address the needs of our catchment area via cancer prevention, control, screening as well
as treatment and imaging studies. The specific aims of the proposed National Capital Area NCORP are to: (1)
Design and participate in clinical trials in cancer clinical research that improves the quality of care and the health
outcomes of the US population in our catchment area; (2) Increase the participation of the greater DC area’s
community oncologists and medical specialists and their patients in NCORP-led clinical research; and (3)
Expand health disparities research focused on clinical research participation via community outreach,
engagement, and education.

Public health relevance
Project Narrative The National Capital Area (NCA) Minority/Underserved NCORP, based at Georgetown Lombardi Comprehensive Cancer Center (LCCC) and comprises MedStar Georgetown University Hospital (MGUH) and MedStar Washington Hospital Center (MWHC), will conduct cancer clinical research towards efforts to reduce cancer-related disparities and health care outcomes. The NCA NCORP will address the needs of our catchment area via cancer prevention, control, screening as well as treatment and imaging studies.